Evaluation of the FcgR mechanisms in the antibody-dependent enhancement of SARS-CoV-2 infection

Abstract
Given the uncontrolled spread of SARS-CoV-2 and the devastating impact on public health, therapeutic
interventions are urgently needed for disease control. Indeed, several biotech and academic groups are currently
focusing their efforts on the isolation and clinical development of monoclonal antibodies (mAbs) with potent
neutralizing activity against SARS-CoV-2. During the past few weeks, a number of neutralizing anti-SARS-CoV-
2 mAbs have entered clinical testing, representing promising therapeutic modalities for the control of COVID-19
disease. In parallel, several vaccine candidates are currently in clinical development or testing, aiming to provide
life-long immunity against SARS-CoV-2. However, a major safety concern for these approaches has been the
potential of antiviral IgG antibodies to enhance, rather than control, infection; a phenomenon termed as antibody-
dependent enhancement (ADE). Although ADE has been primarily demonstrated for flaviviruses, like dengue, it
is unknown whether this phenomenon also extends to coronaviruses, like SARS-CoV-2. Previous studies on
SARS-CoV suggest that IgG antibodies against the Spike protein may promote infection of leukocytes and
modulate disease severity by triggering acute lung injury through excessive or inappropriate activation of pro-
inflammatory pathways. This pathogenic activity is proposed to be mediated through the interaction of their Fc
domains with FcγRs expressed on the surface of effector leukocytes. Given the ongoing clinical development
efforts for antibody-based therapeutics and vaccines to control SARS-CoV-2 infection, it is important to assess
whether anti-SARS-CoV-2 antibodies have the capacity to mediate ADE and if so, determine the precise
molecular mechanisms and the role of FcγRs in this process. A major obstacle in the study of human Fc function
in vivo is the substantial interspecies differences in the FcγR biology between humans and other mammalian
species, necessitating the development of novel animal strains that recapitulate the unique complexity of human
FcγR structural and functional attributes. To overcome these limitations, the proposed studies aim to develop
novel mouse strains and hamster models of SARS-CoV-2 infection, which will be used to systematically evaluate
the in vivo pathogenic activity of a panel of anti-SARS-CoV-2 mAbs and polyclonal IgG antibodies from recovered
COVID-19 patients. By comparing the capacity of Fc-engineered mAbs with defined FcγR binding profile to
mediate ADE of SARS-CoV-2 infection, the proposed studies will provide novel insights into the in vivo ADE
activity of anti-SARS-CoV-2 IgG antibodies, characterizing the precise FcγR pathways that contribute to disease
pathogenesis.

Public health relevance
Narrative In response to SARS-CoV-2 infection, antibodies are elicited, contributing to antiviral protection. However, it is possible that antibodies could also increase infection and exacerbate disease, a phenomenon termed as antibody-dependent enhancement (ADE). The proposed studies aim to characterize the capacity of anti-SARS- CoV-2 antibodies to mediate ADE and determine the mechanisms that drive these pathogenic activities.